A Multi-Site Feasibility Trial to Support Implementation of Vestibular Rehabilitation Therapy for Dizziness and Vertigo in the Emergency Department

PROJECT SUMMARY
Dizziness is a common problem affecting nearly 37 million U.S. individuals annually and accounting for 2
million emergency department (ED) visits per year. Dizziness presents a substantial diagnostic challenge for
clinicians because of its broad differential spanning both benign and serious diagnoses; dizziness-related
language is also frequently used by patients to describe symptoms from non-balance related conditions. Thus,
ED visits for dizziness commonly result in low value diagnostic testing (e.g., computed tomography, magnetic
resonance imaging) and unnecessary hospital admission, which in turn contributes to escalating healthcare
costs. Patients suffering from dizziness report reduced quality of life, anxiety, and depression, in addition to a
substantial number of lost working days and time spent seeking healthcare. Fortunately, vestibular
rehabilitation therapy delivered by physical therapists in the outpatient setting has been shown to improve
dizziness symptoms for a number of balanced-related conditions. Whether vestibular rehabilitation therapy can
be delivered by physical therapists in the emergency care setting – where patients have received little to no
prior medical evaluation – is currently unknown but represents vast potential for benefit. This multi-site
feasibility trial will evaluate the feasibility of emergency department vestibular rehabilitation therapy for patients
with undifferentiated dizziness in two diverse health systems in Chicago, IL and Salt Lake City, UT. We will
also gather qualitative data on contextual implementation determinants and preferred implementation
strategies among stakeholders at multiple levels in preparation for a future multi-site hybrid effectiveness-
implementation trial.

Public health relevance
PROJECT NARRATIVE Dizziness is a common problem affecting nearly 37 million U.S. individuals annually and accounting for 2 million emergency department visits per year, and patients suffering from dizziness report reduced quality of life, anxiety, depression, and time spent at work. Physical therapy for dizziness symptoms (called vestibular rehabilitation therapy) can improve dizziness-related symptoms for a number of balance-related conditions but is traditionally offered only in outpatient clinics and after a referral by primary clinician. This multi-site feasibility trial will evaluate whether it is feasible to deliver vestibular rehabilitation therapy directly in the emergency department so that it can be delivered to patients in a timely, equitable, and effective manner; this trial will also give us important information on how to best implement this care model at other emergency departments.